Adverse Health Outcomes From Extreme Heat, Air Pollution, and Medications in Low-Income Pregnant Women and Their Offspring

Climate change constitutes “the single biggest health threat facing humanity”. Climate change exacerbates
heat-related morbidity and mortality due to more frequent, longer and extreme heat events. It also increases
wildfire occurrence and worsens air pollution, which is linked to thromboembolic and bleeding events. The
health impacts of extreme heat and air pollution will only intensify as a result of the changing climate. Certain
subgroups are disproportionately affected, including low-income populations. Pregnant women and their
children, especially those from low-income communities, are particularly vulnerable to harms from extreme
heat and air pollution, not only due to physiologic changes during pregnancy and social vulnerability, but also
because of the medications that are taken in pregnancy to treat chronic diseases, mental health conditions,
and pregnancy complications. Nearly two-thirds of pregnant women in the US take at least one prescription
drug other than vitamins, and medication use is likely to play an important role in modifying the health effects of
heat and air pollution and/or further increasing morbidity in vulnerable pregnant patients and their offspring.
However, the current evidence assessing adverse perinatal outcomes in relation to heat and air pollution lacks
adequate consideration of individual-level factors including medication use and interactions between
medications and other risk factors. While the CDC recently published guidance for heat and medications
recognizing the significance of environment-medication interactions, evidence is still limited, especially for
pregnant women. In the present proposal, an interdisciplinary team of experts in climatology, environmental
and pharmacoepidemiology, obstetrics, congenital abnormalities, data science, and biostatistics will work
closely to design a series of observational epidemiologic studies. We will link temperature/humidity and air
pollution data with national Medicaid data as well as birth registry data from New Jersey, Massachusetts and
California and analyze the linked data using the state-of-the art study designs and analytic methods. Our study
aims to: (1) assess the independent and synergistic effects of extreme heat and prescription opioids and other
heat-sensitizing medications on heat-related adverse events in low-income pregnant women; (2) assess the
independent and synergistic effects of air pollution, i.e., particulate matter (PM2.5), and medications associated
with thromboembolic and bleeding events on these outcomes; and (3) assess the independent and synergistic
effects of extreme heat/air pollution and potentially teratogenic medications on the incidence of congenital
abnormalities. The results of our study will quantify the effects of extreme heat and air pollution exposure and
their potential interactions with medication use in low-income pregnant women while also shedding light on
potential mechanisms that confer increased risk to certain individuals. The evidence generated from our study
will have a direct impact in shaping adaptation strategies and policies for climate change to protect vulnerable
populations from the effects of extreme heat and air pollution.

Public health relevance
The health impacts of extreme heat and air pollution will only intensify as a result of the changing climate. Low- income pregnant women are at risk not only due to socioeconomic vulnerability and chronic health conditions, but also potentially because of some prescription medications taken during pregnancy. The proposed study will assess the interactions between extreme heat, air pollution, and medication use in low-income pregnant patients and will produce evidence that will have a direct impact to guide clinical and policy decisions to protect this vulnerable population from extreme heat and air pollution while providing new insights on underlying biological mechanisms.